Center for Addiction and Disease Risk Exacerbation

PROJECT ABSTRACT
Substance use (SU) negatively affects the risk, management, progression, and outcomes of chronic disease
and contributes to socioeconomic and racial/ethnic health disparities. Although linkages between SU and
chronic disease are well documented, biopsychosocial mechanisms underlying these linkages are poorly
understood. Prospective, longitudinal studies that investigate links between SU and chronic disease are
needed to inform the development of targeted prevention and intervention efforts. In Phase I of this Center of
Biomedical Research Excellence (COBRE), titled Center for Addiction and Disease Risk Exacerbation
(CADRE), we made considerable progress toward establishing a multidisciplinary research center of
excellence that will be sustainable in this important area. With support from our Administrative and Clinical
Laboratory Cores, we provided 11 early stage investigators (ESI) with research funding and career
development to support their transition to research independence. Our CADRE team published 612 peer-
reviewed articles, 147 of which were directly CADRE-supported, and 4 (of 6) of our initial cohort of Project
Leaders (PL) have obtained R01s. In Phase II of the CADRE, we propose to continue to support ESIs leading
thematically and technically linked studies. Our three initial Phase II PLs will (1) examine effects of alternative
nicotine delivery products on smoking, obesity, and relevant clinical outcomes among people with obesity who
smoke (Murphy); (2) investigate the impact of cannabis use and social determinants of health on maternal
mental health in pregnant individuals, specifically focusing on people of color (Gunn); and (3) investigate the
intergenerational effects of parental alcohol use on child externalizing disorders, a predictor of health problems
over the life course (Micalizzi). CADRE PLs and Pilot Project Leaders (PPLs) will benefit from mentorship by
faculty mentors who will provide guidance on research, publication, and grantwriting. As in Phase I, the
Administrative Core will continue to provide organizational structure and state-of-the-art mentoring; administer
the Pilot Projects Program; support diversity and health disparities work; and lead evaluation of all RPs and
center components. The Clinical Laboratory Core will continue to provide research infrastructure and resources
to the PLs and PPLs, thereby enhancing investigator productivity and promoting research rigor and
reproducibility. New to Phase II is a Recruitment, Engagement, and Community Health (REACH) Core that will
provide direct support for local, face-to-face and digital recruitment, to help CADRE ESIs meet their enrollment
and inclusion goals. Through innovative and interdisciplinary research, conducted across multiple levels of
analysis and focused on related questions using common resources and learning experiences, the CADRE will
not only contribute new knowledge, but will continue to serve as the nexus and path toward independence for
the next generation of scientists.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE The research program of this center focuses on the impact of substance use on risk for, development, and progression of chronic diseases. Better understanding of this relationship is expected to benefit individuals with substance use disorders and/or chronic diseases. The center’s projects are led by early career scientists to prepare them for advanced research careers in service of public health.